Animal Models of Suicide: Behavior, Neurobiological and Molecular Phenotypes

SUMMARY – PROJECT 2
The experience of childhood adversity in the form of neglect/abuse is a major risk factor for future suicidal
behavior perhaps via long-term changes in molecular and neurobiological substrates of depression and
impulsivity/aggression. The effect of early life adversity interacts with genetic vulnerability to confer heightened
risk of psychopathology and adverse health outcomes. The mechanistic links between childhood adversity,
genetic risk, molecular/neurobiological pathways, and suicide risk have yet to be established. We propose to
investigate key hypotheses regarding: 1) whether childhood adversity interacts with 5-HT1A genotype to
generate heightened risk of suicide behavioral; 2) the relationship between environment and genetic risk for
suicide on the brain transcriptome and epigenetic variation; 3) the impact on peripheral and brain inflammatory
pathways of the combined effects of environmental and genetic vulnerability to suicide behavior and the
relationship of these inflammasome measures to risk behavioral phenotypes. We propose to use mouse
models as mice are especially well suited to mechanistic studies and transgenic manipulations. Our
experiments are designed to parallel the molecular, neurobiological and immune outcomes in human studies
within the center and can thus readily inform the other projects. In Aim 1, we will investigate whether suicide-
relevant phenotypes in mice (depressive-like, impulsivity/aggression) are heightened through a combination of
early life adversity (maternal separation) and a targeted genetic manipulation of the 5-HT1A system that results
in elevated expression of 5-HT1A autoreceptors and subsequent decreased 5-HT levels. Aim 2 determines
whether early adversity and elevated 5-HT1A autoreceptor levels in the brain result in an altered hippocampal
and prefrontal cortex transcriptome (using RNA-Seq) and variation in DNA methylation within the BDNF and
Nr3c1 genes (using bisulfite pyrosequencing). In Aim 3 we will explore the inflammatory consequences of
genetic and environmental vulnerability to suicide behavior and the relationship of these measures to specific
suicide behavior phenotypes. To achieve this aim, we will profile cytokine levels within the blood, hippocampus
and prefrontal cortex of mice that have experienced postnatal maternal separation combined with elevated
expression of 5-HT1A autoreceptors and assess microglial activation within the brain as a consequence of this
gene-environment interaction.